EHR-based Genomic Discovery and Implementation [Funded Extension]

In phase IV of eMERGE, a single, Network-wide, combined risk assessment and management protocol was
implemented across the various groups represented in the 25,000 patients recruited at 10 sites in the United
States (US). Polygenic risk scores (PRS) were returned for 10 conditions, family history was ascertained using
the MeTree or backup survey and monogenic basis was assessed for Tier 1 conditions. In this Supplement
application we propose to finalize analysis-ready datasets, ascertain near term outcomes within 1 year after
return of results (RoR), assess response of providers and participants to the return of Genome Informed Risk
Assessment (GIRA). Our specific aims for the extension year are: Aim 1. Create a curated dataset of
eMERGE IV participants for analyses. Using data from Common Data Platform (CDP), surveys, and the EHR,
finalize an analysis ready data set for assessment of outcomes and genomic discovery. Along with genomic
data from Broad and Invitae, phenotype dataset will be placed in ANVIL and we will deploy Tanagra and 12b2
to analyze data. Aim 2. Ascertain near-term outcomes after return of GIRA through automated and manual
abstraction. We will use novel phenotyping methods described in Aim 1. We will compare the accuracy of EHR
algorithms with and manual abstraction. Outcomes will include process, intermediate and clinical outcomes
and will be assessed Network-wide as well in a condition-specific manner. We will explore phenotype
abstraction using Large Language Models. Aim 3. a) Clinical informatics and EHR integration Continue to
develop an ecosystem to store GIRA in the EHR and develop computable representation of the PRS report to
enable automated generation of clinical decision support (CDS). b) Investigate ELSI aspects including
assessing responses to PRS return among patients and providers. Aim 4. Genomic discovery using the EHR.
We will compare predictive value of the PRS, family history and monogenic conditions for disease, stratifying
by self reported race/ethnicity. We will also compare the predictive value of SDOH to PRS and jointly model
both to improve risk assessment. Genomic data from Broad and Invitae will be placed on AnVIL will enable
numerous analyses including computing updated PRS and also PRS for conditions that were not selected for
clinical deployment, e.g., abdominal aortic aneurysm and deep vein thrombosis.

Public health relevance
In this Supplement application we propose to finalize analysis-ready datasets, ascertain near term outcomes within 1 year after return of results, develop approaches to enable integration of polygenic risk information in the electronic health record, assess response of providers and participants to the return of Genome Informed Risk Assessment (GIRA), and conduct analysis to assess whether adding social determinants of health to genetic risk factors improves risk assessment.